Gut dysbiosis and tryptophan metabolism in lupus

Summary
Gut microbial dysbiosis has become appreciated as a major intrinsic environmental contributor to lupus
pathogenesis, with cross-sectional studies in patients with systemic lupus erythematosus (SLE), and in mouse
models of the disease showed the presence of globally different gut microbial communities at time of high
disease activity, when compared to healthy controls (HCs). About 40% of patients with flares of lupus nephritis
had intestinal expansions of Blautia (Ruminococcus) gnavus (Rg) and concomitant production of high-level
serum antibodies (Ab) to a novel membrane lipoglycan (LG) produced by certain Rg strains, demonstrating that
LG passed through a functionally impaired gut barrier to activate the peripheral immune system. In a murine gut
colonization model, induction of serum anti-LP IgG antibodies correlated with spontaneous production of anti-
dsDNA IgG and high lupus disease activity. Colonization with Rg isolates from SLE patients altered the intestinal
barrier and promoted autoAb production in healthy B6 controls through vertical transmission. We have shown
that gut colonization by fecal microbiota from the B6.Sle1.Sle2.Sle3 triple congenic (TC) lupus-prone mice
transfers autoimmune activation in B6 mice without bacterial translocation. Instead, TC mice present a skewed
tryptophan (Trp) metabolism that is largely of bacterial origin, and that promotes CD4+ T cell activation. In this
model, autoimmune activation and the composition of the microbiota were altered by manipulating dietary Trp
levels. A skewed serum and fecal Trp metabolism correlate with disease activity in SLE patients. Recent reports
showed that bacterial Trp metabolites play a major pathogenic role in mouse models of SLE, MS, and RA, three
autoimmune diseases with documented gut dysbiosis. In support of a causal relationship between a dysbiotic
Trp metabolism and lupus, we have shown that high dietary Trp promotes Rg blooms in TC mice associated with
gut inflammation and autoimmune activation. Rg depletion ameliorated disease while colonization of TC mice
with LG-producing RG2 but not LG-producing “naked” RG1, promoted autoAb production and T cell activation.
Moreover, RG1 and RG2 process Trp differently, and Trp enhanced the growth of Rg2 but not Rg1. Therefore,
Rg is present in TC mice where it is expanded by Trp, and it is sufficient to accelerate disease. These results
support the premise that Rg blooms are a major driver of lupus pathogenesis, and that we have the tools to
address the mechanisms by which it occurs. We propose in the second cycle of funding of this project to identify
the factors that are necessary for Rg to bloom (Aim 1), and to determine the mechanisms by which Rg promotes
disease, either directly by interacting with the immune system (Aim 2) or indirectly by modifying the intestinal
microbiota (Aim 3). Rg is the only bacteria species associated with lupus pathogenesis in both humans and mice.
The proposed experiments will bring an understanding of the novel mechanisms by which this pathobiont
expands preferentially in lupus hosts and enhances autoimmune activation, which could lead to a better targeted
and effective therapeutic approach to treat this disease.

Public health relevance
Project narrative Gut microbial dysbiosis has recently become appreciated as a major contributor to lupus pathogenesis. A better understanding of the mechanisms by which specific bacteria are found in greater abundance in lupus patients and produce deleterious immune responses offer potential targets for therapeutic interventions. The goal of this project is to use mouse models to unravel these mechanisms for a specific bacteria that is over-represented in lupus patients with severe disease in which it elicits an immune response, and that accelerates lupus in mice.